Administrative Core

The objective of the Administrative Core is to promote, facilitate, coordinate and evaluate multidisciplinary research. This Core is also designed to catalyze and enhance synergistic interactions among Cores and research Projects. The Core has 4 Specific Aims: Aim 1. Promote synergies, coordination and communication in Programmatic research: 1.1. Organize regular scientific meetings and annual retreat of the faculty members, postdoctoral fellows, students and staff under the aegis of the Program to integrate and enhance Projects; 1.2. Provide a state of the art interactive searchable database for procedure, reagent tracking and teaching (PROSTA). Aim 2. Provide biostatistical support, quality control, teaching and develop specialized techniques as required by Projects and Cores. 2.1. Provide on-going statistical support in the design and analysis of experiments. 2.2. Development or application of novel statistical methodology. 2.3. Provide Data Quality Control and Training in Statistical Methods Aim 3. Provide ongoing scientific evaluation of the Projects and Cores and the overall efficiency and cost effectiveness of the Program. The Program's Steering Committee chaired by Drs. Theodorescu, Weber and Conaway will meet monthly to review the performance of all Projects and Cores. This will be complemented by yearly meetings with internal and every other year with external advisors. The Administrative Core will be evaluated by directors of Core units and Project Leaders. Aim 4. Provide administrative support to tasks in Aim 1-3 as required by Program participants.